Improving Quality of End-of-Life Care for Veterans Receiving Hospice in Community Nursing Homes

Background: With the aging of the Veteran population, the demand for end-of-life (EOL) care,
including hospice services, is increasing. VA commits to ensuring that Veterans have access to
high-quality hospice in their setting of choice. In addition to home hospice services, VA offers to
provide hospice care within VA Community Living Centers (CLCs; i.e., VA nursing homes) or in
VA-contracted community nursing homes (CNHs). Until recently, little was known about the
quality of EOL care provided to Veterans receiving CNH-based hospice care. Our preliminary
work found that an alarmingly low percentage (58%) of family members of Veterans receiving
hospice in CNHs gave an “excellent” rating of the overall care received in the last 30 days of life
(compared to 83% of families of Veterans who received hospice in CLCs). We have also
observed significant variation across CNHs in quality of EOL care ratings.
Significance: CNHs are playing an increasingly critical role in VA’s commitment to ensuring
Veterans’ access to hospice care. A comprehensive understanding of the structures and
processes that underlie variation in quality of EOL care provided to Veterans receiving CNH-
based hospice is needed to illuminate levers for intervention to improve quality. Our study aligns
with HSR&D’s priority areas related to Community Care and Long-Term Care and Aging and
VA’s Strategic Plan that includes a key focus on “Aging, Frail, and End-of-Life Veterans.”
Innovation and Impact: Our application of positive deviance and machine learning methods to
identify factors underlying the quality of CNH-based hospice care are innovative contributions to
the field of EOL care research. Our findings have high potential for impact to guide VA
contracting decisions and the delivery of CNH-based hospice care to Veterans.
Specific Aims: 1) Examine the associations between CNH and hospice agency structural
characteristics, EOL care processes and bereaved family ratings of overall EOL care quality for
Veterans receiving hospice in CNHs; 2) Identify high- and low-performing CNHs based on the
BFS overall rating for Veterans who receive hospice; and determine the structures and EOL
care processes that are associated with high and low performance; 3) Explore bereaved family
member perceptions of the quality of EOL care for Veterans who received hospice in high- and
low-performing CNHs; and 4) Understand the delivery of CNH-based hospice care for Veterans
in high- and low-performing CNHs from the staff perspective.
Methodology: The project will employ a sequential explanatory mixed methods design. The
quantitative phase will use multi-level logistic regression models to understand the structural
characteristics and EOL care processes associated with BFS overall ratings (Aim 1) and a
machine learning approach to identify and study high- and low-performing CNHs based on BFS
ratings (Aim 2). The qualitative phase will deepen our understanding of the delivery of hospice
care in high- and low-performing CNHs using existing BFS data collected from bereaved family
members (Aim 3) and interviews with clinical staff and administrators (Aim 4).
Next Steps/Implementation: Findings will be used to refine VA’s CNH Dashboard that is used
to guide contracting decisions by incorporating EOL-focused measures. The study will also
create a Roadmap for Improving CNH-Based Hospice Care, including a Compendium of Best
Practices, that will inform quality improvement efforts and the development of a future
intervention study.

Public health relevance
VA is a national leader in the provision of high-quality hospice and palliative care, particularly in VA Community Living Centers (CLCs). Yet the demand for CLC-based hospice care has outpaced supply, a gap that is expected to increase with the aging of the Veteran population. To address this need, VA contracts with community nursing homes (CNHs) and hospice agencies to provide CNH-based hospice care to Veterans. Our preliminary work has revealed that quality ratings of EOL care provided in CNHs are soberingly lower than in VA CLCs. Thus, VA must identify ways to improve quality of EOL care in CNHs. This novel project uses a mixed methods design to develop a rich understanding of the structural characteristics and care processes that are associated with the provision of high-quality CNH-based hospice care. The results will be used to inform policies and practices that improve the quality of EOL care provided in CNHs.